Mediterranean diet, Metabolites, and Cardiovascular Disease

ABSTRACT
Metabolomics technique holds promise for better understanding the role of diet in cardiovascular disease (CVD)
epidemiology and prevention. In particular, a multi-fluid multi-metabolite approach combining urinary and
plasma metabolomics will likely enhance the accuracy and precision of nutritional biomarkers, with strong
potential to develop novel tools for dietary assessment in precision nutrition research. This competing renewal
is aimed to examine the effects of the randomized Mediterranean diet (MedDiet) interventions on urinary
metabolite levels and to assess dietary biomarkers' predictive ability for future CVD risk in the landmark
PREDIMED trial. We will assess urinary metabolomics in relation to CVD through a case-cohort design,
including a representative subcohort randomly sampled from all PREDIMED participants (10%, n=779), and
incident CVD cases (including myocardial infarction (MI), stroke, heart failure, and cardiovascular deaths)
through December 2017 (n=529). The proposed Specific Aims are: (1) To identify specific urinary metabolites
and multi-metabolite signatures of the MedDiet pattern and its main food components; (2) To examine the
effects of the randomized dietary interventions on changes in the urinary multi-metabolite signatures of the
MedDiet pattern and its major food components from baseline to year 1 (post intervention); (3) To investigate
whether baseline and 1-year changes in urinary multi-metabolite signatures of the MedDiet pattern and of
individual foods are associated with subsequent risk of CVD; and (4) To develop a multi-fluid (urine and
plasma) multi-metabolite signature that robustly predicts risk of CVD and assess whether 1-year changes in
the signature mediate the effects of the dietary interventions on the composite CVD outcome. As a sub-aim, we
will compare the predictive roles of plasma and urinary metabolites of the MedDiet pattern on CVD risk. This
ongoing grant started in 2013 and was renewed in 2017. To date, 36 papers have been published or
submitted (including 20 papers in the current grant cycle). The PREDIMED metabolomics data have been
used as a resource for replicating metabolomics analyses of CVD outcomes in several US cohorts. This
competing renewal application will extend our long-standing research on MedDiet and CVD to multi-fluid multi-
metabolite profiling in a large randomized intervention trial. This project leverages numerous strengths of the
PREDIMED trial, a multi-disciplinary and highly productive team, cutting-edge metabolomics technologies, and
high-dimensional data analytics. The identified dietary biomarkers will enhance the quality and rigor of
nutrition research and strengthen the evidence base for developing dietary recommendations and nutrition
policies. The proposed work will facilitate the precision nutrition research agenda outlined in the 2020-2030
Strategic Plan for NIH Nutrition Research.

Public health relevance
PROJECT NARRATIVE The landmark PREDIMED trial has demonstrated that Mediterranean dietary interventions significantly reduced the risk of major cardiovascular disease (CVD) events by approximately 30%, compared to a control diet. The goal of this competing renewal is to examine the effects of the Mediterranean dietary interventions on changes in urinary levels of metabolites and develop a multi-fluid (urine and plasma) multi-metabolite signature that significantly predicts future risk of CVD. The study has the potential to discover novel pathways through which diet influences CVD risk and facilitate the precision nutrition research agenda outlined in the 2020-2030 Strategic Plan for NIH Nutrition Research.